Spatial Acetyl-CoA metabolism as a regulator of Hallmarks of Aging

ABSTRACT
Genotoxic stress is a key hallmark of aging. Interestingly, and of great relevance to aging research, nuclear DNA
damage is inextricably linked to multiple aging hallmarks including: epigenetics, proteostasis, loss of stress
resilience and cellular senescence. However, where, when and how does genotoxic stress drive the other
hallmarks is not well-understood. Our overall premise is that acetyl-CoA metabolism is the ‘hub’ that regulates
these multiple aging hallmarks and determines aging trajectories. Acetyl-CoA is a critical metabolite that
modulates several cellular processes including the gene transcription and protein stability. Acetyl-CoA is tightly
regulated in subcellular pools and a change in concentration or subcellular flux drives quantitative changes in its
availability and utilization. The goal of this project is to address the role of DNA damage-driven acetyl-CoA
subcellular localization and flux as the ‘hub’ of hallmarks of aging. We hypothesize that (1) generation and
spatial distribution of acetyl-CoA are altered in response to DNA damage, and (2) rewiring of acetyl-CoA
metabolism is necessary and sufficient to change aging trajectories. We will test this hypothesis in multi-layer,
mechanistic detail using an innovative combination of genetic, metabolic and biochemical techniques. Lack of
specific tools to induce physiologically relevant DNA damage has severely limited our ability to understand how
genotoxic stress communicates with the rest of the hallmarks of aging. To address this, we created a
chemoptogenetic tool to induce oxidative DNA damage in a controlled manner. This innovative tool will allow us
to directly test whether DNA damage alters hallmarks of aging in a cell autonomous or non-cell autonomous
manner. First, we will determine the timing and hierarchy among the hallmarks of aging in multiple cells/tissues
across the normal lifespan, in response to DNA damage. In addition, we will determine the role of a key metabolic
enzyme, ATP-citrate lyase ACLY in DNA damage-driven acetyl-CoA metabolic rewiring. Second, we will
quantitatively dissect acetyl-CoA subcellular pools and their contribution to senescence and senescence
associated secretome (SASP). Using computational tools to build a unified framework, we will identify causal
hallmarks. This work is technically innovative for quantitatively examining the subcellular regulation of acetyl-
CoA in response to DNA damage with age. This project is intellectually innovative for hypothesizing a novel
relationship between persistent genotoxic stress and subcellular acetyl-CoA metabolism. Our analysis, will
increase fundamental understanding of the connection between DNA damage-induced acetyl-CoA metabolism
and aging hallmarks, thus potentially paving the way for new treatment strategies targeting co-morbidities and
polypharmacy in the elderly.

Public health relevance
PROJECT NARRATIVE This project is relevant to public health given that DNA damage is unavoidable and persistent DNA damage promotes biological aging. Here, we will investigate acetyl-CoA metabolism as the ‘metabolite hub’ that interconnects multiple hallmarks of aging in response to DNA damage. Deciphering the regulatory network upon genotoxic stress is anticipated to uncover potential therapeutic targets that could prevent the progression of a wide range of age-related degenerative diseases.